Epigenetic regulation of transcriptional programming

ABSTRACT
Cell type-specific transcriptional programming enables a single fertilized egg to make the remarkable
transition to become a multicellular organism. The requisite sequence of gene expression transitions is
the result of a collaboration between cell type-specific transcription factors and broadly expressed
chromatin regulators. Historically, my group has made significant contributions to understanding the
targeting and spreading of chromatin domains, and currently we are probing the ability of modular
chromatin factors to respond to local concentrations of transcription factors and their co-activators to
specify cell type. Our studies focus on the dynamic competition between Polycomb (PcG) and Trithorax
group (TrxG) proteins, and due to the high conservation of these key regulatory factors we move
between fly embryos and mammalian cells with ease. We have recently contributed to the recognition
of the ancient conservation of alternative forms of PcG complexes, and over the next funding period
we will investigate the distinct molecular roles that must underly this remarkable conservation. To
understand when, where, and how variant Polycomb complexes function, the Drosophila melanogaster
embryonic and germline systems harbor special promise for key aspects of this work. In particular,
emerging approaches in the germline will allow us to dissect the earliest events in the establishment of
PcG/TrxG regulation. A key challenge will be to adapt current methods to integrate alternative
configurations of protein complexes with their local binding patterns and genetic knockdown
phenotypes. For example, we have discovered that a Pho/Sfmbt protein module can interact with co-
activators as well as variant PRC1.6 complexes in Drosophila embryos, and we will test whether these
are modular interactions that vary on a gene-by-gene basis during normal development. We will also
analyze aberrant epigenetic programs in mammalian cells, in light of the important role that a dynamic
PcG/TrxG competition plays in human malignancies. Focusing on chromatin-driven cancers caused by
aberrant TrxG fusion oncoproteins such as MOZ-TIF2 will complement our analyses of normal cell type
transitions. This topic is of key biomedical significance, as plasticity of transcriptional programming is
thought to underlie the devastating facility of cancer sub-populations to acquire drug resistance and to
metastasize. Important benchmarks for our work will be i) identifying the initial steps that poise
developmental genes for activation or repression, ii) providing a mechanistic understanding for how
resolution occurs, and iii) contributing to an understanding of cell state switching in response to cancer
drivers. More broadly, our work will highlight regulation at the level of dynamic protein interactions,
which is likely universal to all biological systems.

Public health relevance
PROJECT NARRATIVE The genomes of multicellular organisms are utilized distinctly over time and space as cells multiply and specialize during normal development. Understanding this process is of critical biomedical significance, as mis-regulation of the human genome underlies many diseases, including the devastating ability of cancer cells to acquire drug resistance and to metastasize. Identifying the initial steps that poise developmental genes for activation or repression, providing a mechanistic understanding for how regulatory decisions occur, and discovering how cells aberrantly switch state in cancer are all critical goals of our research.